Developing a Real-Time Trajectory Tool to Identify Potentially Unsafe Concurrent Opioid and Benzodiazepine Use among Older Adults

Project Summary/Abstract Prescription opioid overdose deaths have increased markedly in the past two decades, with a third of these fatalities involving concurrent benzodiazepine (BZD) use. Despite clinical guidelines and FDA black-box warnings cautioning against concurrent opioid (OPI) and BZD use (hereafter OPI-BZD use), the number of patients using OPI-BZD increased by 41% between 2002 and 2014. OPI-BZD use increases the risk of overdose and other adverse outcomes (e.g., falls, fractures, cognitive dysfunction), especially among older adults. The dose and duration of OPI-BZD use varies by patient characteristics and comorbid conditions. However, little is known about the thresholds of duration and dose or patterns of OPI-BZD use profiles most associated with the risk of overdose and other adverse outcomes among older adults. Prior studies have defined OPI-BZD use with arbitrary thresholds (e.g., ≥1 day overlapped supply) and focused only on duration or dose alone rather than combinations of duration and dose of concurrent use. Applying arbitrary and broad thresholds without evidence and validation to all patients imposes challenges in tailoring clinical care, and leads to ineffective therapies and interventions involving OPI-BZD use. Alternatively, advanced group-based trajectory models (GBTMs) can be used to better characterize OPI-BZD use in clinical practice. GBTMs have the ability to account for dynamic medication use, identify subgroups with similar changes over time, and simultaneously examine dose and duration thresholds or other patterns most relevant to outcomes in order to better aid clinical decision-making. The proposed study aims at developing an innovative, real-time “Predicting Risky Opioid-Benzodiazepine Trajectory e-Care Tool (PROTeCT)” for efficiently identifying and predicting subgroups of older adults (aged ≥50 years) with distinct and potentially unsafe patterns of OPI-BZD use. Because both Medicare and Medicaid enrollees are experiencing an increased number of chronic pain conditions, mental health/substance use disorders, and prescription OPI use, Medicare and Medicaid are ideal settings for developing the PROTeCT tool. Using national Medicare claims and Arizona (AZ) and Florida (FL) Medicaid data from 2013-2016, Aim 1 focuses on identifying distinct trajectories of OPI-BZD use. We will also identify predictors associated with specific trajectories or patterns. In Aim 2, we will identify the distinct trajectories or patterns of OPI-BZD use that are the most closely associated with two separate outcomes (i.e., overdoses; falls and fractures). Finally, we propose to develop a beta-version of a real-time PROTeCT platform capable of prospectively and iteratively predicting patients with unsafe patterns of OPI-BZD use by prospectively analyzing more recent data from the 2017-2019 Medicaid in AZ and FL. The infrastructure of our findings and tool may be generalizable to Medicare, Medicaid programs in other states or other healthcare data systems with similar data structures.

Public health relevance
NARRATIVE Harnessing the innovative and advanced group-based trajectory modeling (GBTM) approach, the proposed study aims at developing an innovative, real-time “Predicting Risky Opioid-Benzodiazepine Trajectory e-Care Tool (PROTeCT)” for identifying and predicting subgroups of older adults with potentially unsafe patterns of OPI-BZD use. To overcome the gaps in the prior studies using arbitrary thresholds of duration and dose alone, the PROTeCT platform developed from the proposed study has the ability to simultaneously examine dose and duration thresholds or other patterns most relevant to outcomes and incorporate prescription data in a prospective manner. Our findings and PROTeCT platform will better guide clinical care on co-prescribing opioids and benzodiazepines and inform concurrent opioid and benzodiazepine use related policies and interventions implemented by the Centers for Medicare & Medicaid Services (CMS) and their partners and state programs.